Cancer Center Administration

CANCER CENTER ADMINISTRATION: PROJECT SUMMARY/ABSTRACT

Wilmot Cancer Institute (Wilmot) Administration is the principal organizational component that centrally
operationalizes and promotes Wilmot’s vision, mission, and strategic priorities by providing the overall planning
and management of administrative services to Wilmot’s 115 members. Associate Director for Administration and
Finance Brian J. Martin, MPA, leads Administration, and reports directly to Wilmot Director Jonathan W.
Friedberg, MD, MMSc (CM). Martin, in collaboration with a team of highly qualified and experienced individuals,
provide the administrative and financial support necessary to ensure efficient and effective operations, including
all Wilmot and CCSG related activities. Essential Administration functions include: (1) Cancer Center Support
Grant (CCSG) management, reporting, and application processes; (2) oversight and management of shared
resources; (3) grant pre- and post-award administration and development; (4) human resources, including faculty
recruitment, retention, and promotions; (5) fiscal oversight of all Wilmot functions, ensuring cohesiveness and
alignment of Wilmot’s strategic priorities; (6) outreach and information dissemination; (7) information technology;
(8) strategic planning and evaluation activities; (9) management and oversight of pilot project solicitations; and
(10) space management. In recent years, Wilmot Administration has accomplished a number of notable
milestones, including organizing and developing Wilmot’s 2023-2028 strategic planning initiative, coordinating
the recruitment of 30 new faculty, strengthening Wilmot’s administrative structure through recruitment of
experienced senior leaders, facilitating implementation of policies and processes for effective CCSG
management, and restructuring and expanding CTO and information technology services. Wilmot Administration
is involved in key initiatives at the University of Rochester Medical Center (URMC) that add value to the CCSG.
In response to Wilmot’s needs, Martin partnered with the URMC Office of Clinical Research to bring a new
management system to more efficiently conduct clinical trials. He also serves as a member on key committees
that drive medical center policies with respect to information technology, research administration, compliance
activities, and space planning. Finally, Wilmot Administration has built, enhanced, and strengthened its
capabilities to fully support the CCSG application process and CCSG operations. These capabilities include: the
annual research performance progress report; external advisory board meeting planning and execution;
evaluation; shared resource management support; membership management; space management; policy
development and management; pilot award solicitation, review, and monitoring; research grant administration;
and management of philanthropic and institutional funds. Moving forward, Administration is well positioned to
foster and support implementation and tracking of the Wilmot Strategic Plan, and enhance growth and expansion
through recruitment.